Effect of Mutant HTT on the Development and Maturation of Astrocytes

Project Summary / Abstract:
Astrocytes are known to be dysfunctional in Huntington’s disease (HD); however, further research is needed
to understand how these star-like cells develop in the context of HD. HD is a devastating, progressive, genetic
neurodegenerative disease, and recent work suggests mutant Huntingtin (mHTT), the cause of disease, may
trigger early molecular and cellular changes during neurodevelopment that sets up susceptibility. Data suggests
mHTT impacts the maturation of neural cells into adult life and throughout disease progression. While HD is
primarily characterized by the degeneration of medium spiny neurons in the striatum and atrophy of the cortex,
astrocytes have become a prominent cell type of interest as a contributor to the onset and progression of the
disease. Astrocytes guard and support the brain by stabilizing the blood-brain barrier, responding to stressors,
and regulating ions and neurotransmitter homeostasis, all of which are dysregulated in HD. Our lab at UC Irvine
has shown developmental deficits using single-nuclei RNA sequencing (snRNAseq) in HD human induced PSC-
derived astrocytes (iAstros) and in rapidly progressing R6/2 HD mouse cortex and striatum. We also confirmed
that HD iAstros have decreased RNA and protein of transcription factors (TFs) SOX9 and ATF3, results that
support a role for these TFs in dysregulated maturation and developmental pathways. Lacking in the snRNAseq
from mice is spatial information, thus I conducted spatial transcriptomics of postnatal day 0 (P0), 4-week and 12-
week-old control and R6/2 mice and found early dysregulation of astrocytic developmental genes and a possible
role for neuronal-derived signaling factors in astrocyte developmental impairment. Several questions remain: 1)
whether HD astrocyte dysmaturation is an initial delay of maturation or a persistent impairment, 2) what is
mechanistically driving spatial maturation impairments, and 3) what the impact is of astrocyte deficits on
neighboring cells. I hypothesize that early impairments in astrocyte maturation set up susceptibility to HD
progression later in life. To begin to address these gaps in knowledge, in Aim 1, I will investigate the role of
dysregulated TFs, SOX9 and ATF3, with overexpression and knockdown in iAstros and assess cellular
maturation, function, morphology, and transcriptomic pathways. Aim 2 then utilizes the spatial transcriptomics
data integrated with snRNAseq to evaluate temporal and spatial regulators of regional changes with a focus on
astrocyte development and maturation, and the contributions of neuronal-astrocyte signaling. I will infer cellular
communication between neurons and astrocytes through ligand-receptor analysis and functionally validate my
preliminary findings in vitro with iAstros. This proposal uses innovative approaches to provide the scientific
community with a novel investigation of dysfunctional astrocytic developmental trajectories in HD with the aim of
influencing early therapeutic interventions to impact the onset or progression of disease. My laboratory
environment at UCI and individualized mentorship from my sponsors supporting my research skills in perturbing
in vitro cell models and bioinformatics analysis will help to burgeon my growth as a young scientist.

Public health relevance
Project Narrative: Huntington’s disease (HD) is an inherited, neurodegenerative disorder that debilitates individuals due to uncontrolled movement, changes in personality and loss of cognition. Astrocytes, the guardians of the brain, survey and nourish brain cells and have received growing attention due to their involvement in neurodegenerative pathologies. Research proposed here on HD astrocytes during development and disease progression is imperative to the field to inform efficient disease modifying therapies.